Innovations in Shock Wave Lithotripsy Technology

SUMMARY ABSTRACT
Urolithiasis imposes a substantial and growing public health burden in the United States with a prevalence nearly
doubled over the past 15 years, impacting now 1 in 11 Americans in their lifetime. Shock wave lithotripsy (SWL)
remains to be the only non-invasive treatment option for kidney stone patients despite the advances in
ureteroscopy. The progressive decline in the clinic use of SWL, on the other hand, has been attributed to several
key factors, including 1) no fundamental technology breakthrough with problematic dry coupling technique widely
employed by contemporary shock wave lithotripters, 2) no real-time monitoring of cavitation activity during clinical
SWL, and 3) increased number of shockwaves administered per session with elevated fragment size and non-
successful rate. Overall, addressing these critical issues is urgently needed to improve the efficiency and safety
of SWL, and ultimately, reinvigorate the confidence of urologists in this non-invasive treatment modality for stone
patients. In this competing R01 renewal application, we will leverage the knowledge and expertise that our
interdisciplinary team has accumulated in the past ten years through the R37 program. We will focus on
developing the next-generation SWL, cavitation monitoring, and
miniature
wet coupling technologies as well as
strategies to produce fine stone fragments in SWL with clear translational potentials. We propose three specific
aims: 1) create a SAFE (Steerable and Adjustable Focusing Electrohydraulic) shock wave generator with flexible
focal width and beam orientation, and a miniature wet coupling device, 2) develop 3D Dynamic Cavitation
Monitoring (3D-DCM) technology for safeguarding SWL
while improving stone fragmentation efficiency and
treatment outcome
, and 3) investigate mechanism of surface acoustic wave (SAW) generation and its
contribution to producing fine fragments through synergistic interaction with cavitation in SWL. Achieving these
aims will significantly advance the state-of-the-art research activities in SWL, and further propel technology
development in the field in close collaboration with lithotripter manufacturers. The new technologies envisioned
in this project will improve the safety and efficacy of SWL, while providing the urologist opportunity and flexibility
in tailor-designing the treatment protocol for stone patients under various clinical scenarios.

Public health relevance
PROJECT NARRATIVE Urolithiasis (or commonly known as urinary stone disease) is a benign but severely painful genitourinary disease that is on the rise and is the second most costly urologic condition in the US at over $2 billion per year. Despite the technology and technical advances in ureteroscopy (URS) with laser lithotripsy, shock wave lithotripsy (SWL) remains to be the only non-invasive modality for stone patients, easy to use, cost effective, and can often produce stone free rates comparable to URS. We propose to further advance the technology innovations in SWL by creating SAFE (Steerable and Adjustable Focusing Electrohydraulic) shock wave generators, 3D-DCM (3D- Dynamic Cavitation Monitoring) technology, and a miniature wet coupling (MiniCouple) device, applicable to most clinical shock wave lithotripters, to ensure the quality of shockwave source-patient interface for effective acoustic transmission, and to improve the overall treatment outcome while reducing tissue injury and procedure time .